Developing an in vitro model for cancer pain using all-optical electrophysiology

Project Summary Cancer pain therapeutics comprise more than one quarter of the total pain market. The current treatment paradigm relies on opioids, which are not effective for many patients and can have debilitating side effects for others. Despite the clear societal need for better pain medicines, there has been glacial progress in bringing new drugs to market. This shortfall is due in part to the lack of translatable model systems and tools to rapidly study relevant electrical and synaptic phenotypes associated with pain. We aim to overcome these challenges. The all-optical electrophysiology platform Optopatch, recently developed at Q-State Biosciences and comprised of engineered optogenetic proteins, custom microscopes, and software, makes it possible to simultaneously stimulate (blue light) and record (red light) electrical activity from around one hundred neurons with one millisecond temporal resolution, single cell spatial resolution and high signal-to-noise. The Optopatch platform can be used to study single-cell excitability, synaptic transmission, and network behavior with information content comparable to manual patch clamp, but at dramatically higher throughput. In this application, we propose to create an in vitro model of cancer pain via chemotherapeutics or mimicking the local tumor chemical environment experienced by sensory neurons. We will establish an Optopatch synaptic assay between primary rodent DRG neurons and dorsal horn neurons that will serve as the basis for phenotypic evaluation. Using our Optopatch excitability and synaptic assays, we will develop a “cancer pain soup” that consists of the relevant signaling molecules. This formulation will be validated in vitro using human stem cell-derived sensory neurons as well as in vivo with nociception assays in rodents. We hypothesize that addition of this chemical mixture will lead to a phenotype of hyperexcitability or increased synaptic transmission. We will screen established tool compounds and attempt to reverse the phenotype. The Phase I application will establish the cancer pain in vitro response that can be used for phenotypic drug screening efforts in Phase II to identify novel therapeutics for cancer pain.

Public health relevance
Project Narrative Effective treatment of cancer pain remains a large unmet medical need, as the current standard of care relies on opioids that lack efficacy and lead to debilitating side effects. Q-State has created a platform with engineered optogenetic proteins and custom microscopes to simultaneously stimulate and record electrical activity from hundreds of human or rodent sensory neurons, allowing for a so called “disease in a dish” model of pain. In this application, we propose to create an in vitro model of cancer pain by testing for a hyperexcitability phenotype upon treatment of sensory neurons with either chemotherapeutics or a cocktail of signaling molecules that mimic the tumor local chemical environment; these models will enable future drug screening efforts to identify novel therapeutics for cancer pain.